KPMP in Type 1 Diabetes: A UW Medicine Collaboration

Project Summary
This project will establish a Type 1 Diabetes (T1D) Recruitment Site within the Kidney Precision Medicine
Project (KPMP) at the University of Washington. We bring substantial experience conducting kidney biopsies
among people with T1D, having already completed >130 biopsies as part of multiple successful T1D studies.
Building on established infrastructure for patient-oriented research in T1D, we will obtain research kidney
biopsies and comprehensive phenotyping from individuals with T1D who have or are at risk of chronic kidney
disease (CKD). Our specific aims are to: (1) safely and ethically obtain research kidney biopsies from adults
and adolescents living with T1D who have or are at risk of CKD through robust community engagement and
standardized protocols; (2) robustly phenotype the clinical presentation through advanced imaging
(multiparametric kidney MRI, retinal imaging) and vascular assessment; and (3) actively contribute to
enhanced understanding of CKD pathophysiology through collaborative participation in KPMP team science.
We will integrate expertise from two premier research centers - the University of Washington Medicine
Diabetes Institute (UWMDI) and Kidney Research Institute (KRI) - to enroll 15-20 participants annually. Starting
in Year 2, pending careful ethical consideration with patients and the broader KPMP consortium, we propose
expanding enrollment to include adolescents ≥16 years. Together, this work will advance understanding of
kidney disease in T1D while maintaining the highest standards of patient safety and ethical conduct. By
integrating with KPMP’s existing infrastructure and protocols, our site will contribute to the development of
precise, mechanistic definitions of kidney disease in T1D, ultimately enabling more targeted diagnosis and
treatment.

Public health relevance
Project Narrative Over 1.4 million Americans live with type 1 diabetes (T1D), a number projected to reach 2 million by 2030, with approximately one-third developing chronic kidney disease that significantly increases their risk of cardiovascular disease and premature death. The University of Washington KPMP T1D Recruitment Site will leverage its established infrastructure and expertise to recruit and characterize T1D patients while obtaining high-quality kidney tissue samples. This work will advance our understanding of kidney disease mechanisms while maintaining rigorous ethical standards and patient safety, ultimately enabling the development of more targeted therapies.